Core C - Comparative Organismal Energetics Core

Project Summary – Comparative Organismal Energetics Core
The Comparative Organismal Energetics Core (Organismal Core) provides specialized expertise in the
development and utilization of methodologies, state-of-the-art instrumentation and the selection of animal
models to facilitate understanding the contribution of energetics to biological aging, including nutritional,
genetic, and biochemical interventions that impact aging research. The Organismal Core is a unique resource
for investigators, with services and resources not available elsewhere on campus and available to the broader
(non-UAB) research community. The Organismal Core is ideally suited to measure energy acquisition, storage,
and utilization in a variety of animal models including C. elegans, Daphnia, Drosophila, zebrafish, and rodents,
thereby complementing the overall mission and theme of the UAB Nathan Shock Center (NSC). The Specific
Aims of the Core are as follows:
1. To provide expertise in the area of energetics and body composition in comparative animal models of
aging;
2. To provide state-of-the-art instrumentation and methodology for the determination of body composition
across the lifespan (dual energy X-ray absorptiometry, quantitative magnetic resonance, and micro-
computed tomography);
3. To provide state-of-the-art instrumentation and methodology for the determination of energy balance
across the lifespan (food intake, energy expenditure, energy balance, and activity);
4. To provide state-of-the-art instrumentation and methodology for evaluating healthspan-associated
behaviors across lifespan and species;
5. To develop new methodologies for assessing energetics/body composition where needed in current and
novel organisms for aging research;
6. To provide education and training on procedures and pitfalls in comparative organismal energetics (both
internal and external to UAB).